Molecular Mechanism of Synapse Assembly and Function

The strength of synaptic connections plays a critical role in determining information flow within
neural circuits and establishing how circuits can be modified in response to changing inputs. A
key parameter of synaptic strength is the probability of neurotransmitter release from the
presynaptic neuron. Neurotransmitter release depends on localized calcium influx triggering
fusion of molecularly primed synaptic vesicles at specialized domains of presynaptic terminals
called active zones. We and others have found that conserved proteins of the active zone
cytomatrix regulate key determinants of release probability, including the number of release-
ready synaptic vesicles, calcium channels clustering, and the spatial coupling of vesicles and
channels. Presynaptic release properties vary considerably even between neighboring AZs of
the same neuron. Yet, how proteins of the conserved AZ cytomatrix act locally to generate a
diversity of synaptic strengths is not understood. Emerging observations, including our own
preliminary data, indicate that AZ cytomatrix proteins are differentially deployed at functionally
distinct synapses, suggesting a flexible strategy for achieving functional diversity. Here, we build
on our advances in understanding local determinants of synaptic function to elucidate how
active zones are organized to achieve synapse-specific neurotransmitter release properties
(Aim 1), how synapses are reorganized during plasticity (Aim 2), and how functional
heterogeneity interacts with plasticity to support circuit function in response to changing inputs
(Aim 3).

Public health relevance
To support complex behavior, neural circuits, the functionally connected neurons that give rise to thought and behavior, must be both reliable and flexible. The proposed research extends our advances in understanding the molecules that organize synaptic connections for robust communication to determine how synapses with distinct properties are established and the role of synaptic diversity in allowing circuits to respond to a broad range of changing inputs. Successful completion of our aims will advance understanding of how synapses are organized to support robust and adaptable neural function, and how these processes can be disrupted in diseases states.